Translational Nanobiology Approaches to Viral Diseases (HIV, HTLV, SARS-CoV2)

We established and are maintaining an open-access resource at nano.ccr.cancer.gov wherein protocols and methods for virus and extracellular vesicle (EV) detection or characterization that is developed in this program are shared with the worldwide research community. Since launch of the website, we have been posting updates on a near-weekly basis. Additional open source software relating to extracellular vesicles particles research has been added in 2022 and will be presented in upcoming manuscripts. New 2022 software includes 1) an updated FCMpass package for single EV flow cytometry, 2) post acquisition analysis software for resistive pulse sensing measurements, and 3) multiplex EV repertoire analysis software,